STING agonist-expressing BCG for bladder cancer

Abstract
More than 80,000 Americans are diagnosed with bladder cancer each year, and more than 17,000 die from the
disease. Approximately 75% of new bladder cancer patients present with non-muscle invasive bladder cancer
(NMIBC). Not only is NMIBC associated with high recurrence rates (>50%) and risk of progression, but 30% of
patients are unresponsive to the standard of care treatment: transurethral resection with intravesical Bacillus
Calmette-Guérin (BCG) instillation, the only approved microbial therapeutic for cancer. These individuals are left
with limited therapeutic options. While there have been efforts to generate improved recombinant BCG (rBCG)
strains, such efforts have not yet yielded demonstrable improvement over traditional BCG. With very few
advances in treatment over the past two decades for early stage disease and a limited pipeline of therapeutics
in development, there is a major unmet need for improved treatments for NMIBC. To address this need,
OncoSTING is developing OS-101, a breakthrough rBCG immunotherapy that overexpresses a potent Stimulator
of IFN Genes (STING) agonist. STING agonists potentiate anti-tumor responses through the innate immune
STING-IRF3-NF-κB pathway. While other companies are developing small molecule STING agonists as novel
anti-cancer immunotherapies, OncoSTING is the only company developing STING agonist delivery by a
live bacterial vaccine—BCG—that itself is a well-known immunotherapy already in use for the treatment
of bladder cancer, thus offering the benefits of both. Because it is a live bacteria, OS-101 allows for
continuous and prolonged delivery of the STING agonist to the tumor microenvironment. Compared with wild
type BCG, OS-101 demonstrates superior antitumor efficacy in models of NMIBC; more potent pro-inflammatory
cytokine responses; greater myeloid cell reprogramming, producing an M1 shift with enhanced
phagocytosis/autophagy; more pronounced epigenetic changes in key cytokine promoter regions; and
metabolomic changes favoring antitumor immunity. In Phase I of this Fast Track project, OncoSTING will create
a next-generation, antibiotic resistance-free version of 0S-101 using a novel, patent-pending method. The current
rBCG prototype, OS-101, relies on a bacterial plasmid that is maintained using an antibiotic resistance cassette.
However, Phase 3 studies will require the removal of antibiotic resistance genes. The efficacy of the new
construct, called OS-151, will then be confirmed in four relevant bioassays. In Phase II, OS-151 will be compared
to ADU-S100 (Aduro's small molecule STING agonist which is in current clinical trials) and wild type BCG in
relevant models of bladder cancer. Pre-IND, pharmacokinetic and safety studies of OS-151 will also be
conducted, and optimization work will ensure production of OS-151 at scale. Finally, tumor repetitive dosing
studies and rechallenge studies will be carried out in mouse syngeneic models. Once approved, OS-151 will first
be used to treat patients with BCG-unresponsive NMIBC, with potential to expand to other cancer indications.

Public health relevance
Narrative Of all cancers, bladder cancer— the fifth most common malignancy in the U.S.—has the highest lifetime treatment costs per patient. New patients with non-muscle invasive bladder cancer (NMIBC), a subtype that has high recurrence rates (>50%) and risk of progression, are treated with live, attenuated vaccine Bacillus Calmette- Guérin (BCG) microorganisms as first-line therapy, but roughly one-third develop BCG-unresponsive disease. This project will support the development of a novel therapeutic solution consisting of a recombinant BCG strain with improved effectiveness at promoting a patient's anti-tumor immune responses.